An RNA editing platform to investigate the dynamic RNA interactome

PROJECT SUMMARY/ABSTRACT
A major mechanism of post-transcriptional gene expression regulation occurs through the binding of RNA
transcripts with RNA-binding proteins (RBPs), a large class of cellular proteins consisting of over 1500 members.
Identifying the native substrates of RBPs and characterizing the function of these interactions remains a
significant challenge in biology. Further, oligonucleotides and small molecules that target RNA-protein
interactions and modulate protein expression have been recently deployed in the clinic and promise to provide
a new therapeutic modality for the treatment of human diseases.
We have developed TRIBE-ID, an RNA editing approach to interrogate dynamic RNA-protein interactions in a
small molecule-dependent manner. We applied our approach to profile the RNA substrates of the RBP G3BP1,
a central component of stress granule condensates. Here, we propose to further develop and apply TRIBE-ID
as a general platform to investigate RNA-binding events in cells. We will advance the efficiency and generality
of RNA editing for interactomic studies and investigate the trafficking and post-transcriptional regulation of RNA
stability/translation by cytoplasmic biomolecular condensates. Further, we will develop RNA editing approaches
to investigate small-molecule RNA interactions. Our project has the following specific aims:
Aim 1. Develop an RNA editing platform with improved generality, efficiency, and molecular resolution.
Aim 2: Characterize regulation of RNA stability/translation by biomolecular condensate-forming RBPs.
Aim 3: Develop an RNA editing approach to investigate RNA-binding small molecule therapeutics.
Our findings will provide new approaches for studying dynamic RNA-protein interactions and RNA-binding small
molecules and reveal new insights into the formation and function of phase-separated biomolecular
condensates. These studies should advance our understanding of fundamental RNA regulatory mechanisms
and accelerate the development and characterization of RNA-targeted therapeutics.

Public health relevance
PROJECT NARRATIVE The regulation of RNA in biological systems plays an important role in gene expression programs and defects in this process can lead to human disease. A major mechanism for RNA regulation is through interactions with cellular RNA-binding proteins, and therapeutics that modulate these interactions are currently in development. This proposal seeks to develop a general method for characterizing RNA-protein and RNA-small molecule interactions with application to the development of novel RNA-targeted drugs.